Statistical and Machine Learning Methods to Address Biomedical Challenges for Integrating Multi-view Data

Abstract
Alzheimer’s disease (AD) is a complex and heterogeneous condition that affects 5.8 million adults 65 years or
older in the U.S. AD is the most common cause of dementia and presents a substantial and increasing economic
and social burden. Our ability to diagnose and classify AD from cognitive normals (CN), or discriminate among
individuals with AD, early mild cognitive impairment [EMCI], or late mild cognitive impairment (LMCI), is essential
for the prevention, diagnosis, and treatment of AD. Since individuals with MCI have a high chance of converting
to AD, effectively discriminating between those who convert to AD (MCI-C) from those who do not convert (MCI-
NC) is important for early diagnosis of AD. The heterogeneity of AD has further motivated attempts to classify
distinct subgroups of AD to better inform the underlying physiology. There is evidence to suggest that using data
across multiple modalities (e.g. genetics, imaging, metabolomics) has potential to classify AD subgroups better
than using single modality. However, most AD studies that have used multimodal data have focused on imaging
data or imaging and genetics data only.
The purpose of this study is to innovatively apply state-of-the-art Machine learning (ML) and Deep Learning (DL)
methods we have developed to integrate genetics, imaging, metabolomics, lipidomics, and phenotypic data– from
NIAGADS– to better understand the etiology of AD. Our specific goals are: Aim 1 (a) Identify novel molecular
signatures and pathways likely differentiating AD cases from cognitively normal (CN), MCI converters [MCI-C] from
MCI non-converters[MCI-NC], using multimodal data; (b) Develop polygenic risk scores (PRS) and other molecular
risk scores to identify individuals at a higher risk for developing AD to aid in clinical decision making; Aim 2:
(a) Characterize molecular changes in AD progression and in ethnic groups [exploration study] and (b) Identify
homogeneous subgroups of AD characterized by subgroup-specific molecules and pathways. Although ML and
DL have been successfully used in AD research, their potential have not been fully harnessed.
The proposed research is feasible, promising and potentially significant to AD research. We expect to identify
i) molecular signatures and pathways conferring risk for, or protection against, AD ii) individuals at a higher risk
for developing AD and iii) AD molecular subgroups and subgroup-specific molecular biomarkers and pathways.
Ultimately, our findings have the potential to contribute to AD research by furthering our understanding of AD
mechanisms, refining personalized care, and enhancing our ability to identify targets for disease treatment.

Public health relevance
Project Narrative We propose to innovatively apply state-of-the-art maching and deep learning methods for integrating multimodal data pertaining to Alzheirmer’s disease (AD). We expect to identify molecular signatures and pathways conferring risk for, or protection against, AD; identify individuals at a higher risk for developing AD; and detect AD molecular subgroups and subgroup-specific molecular biomarkers and pathways. These findings are essential for early detection, prevention, diagnosis, and treatment of AD.